PeriPath: A Single Incision Delivery Tool for Epicardial Pacing and Defibrillation: Phase 2

Project Summary
Each year, nearly 7,200 infants in the United States are born with a complex congenital
heart disease that requires surgical intervention within the first year of life. For infants and young
children with heart rhythm abnormalities, interventional treatment can be especially difficult, as
the size of their vasculature and/or congenital anomalies typically preclude a transvenous
approach for implanting a cardiac device such as a pacemaker or defibrillator. As a result, infants
must undergo a sternotomy or thoracotomy to access the epicardial surface of the heart. We have
developed a novel minimally-invasive pericardial access tool to deliver pacing and defibrillation
leads to the epicardial surface of the heart under direct visualization from an endoscope. Utilizing
this tool, we hypothesize that we can safely and effectively deliver pacing and defibrillation therapy
through a single small port. By using a percutaneous approach, this should reduce pain and risk
of infection, decrease procedure times, and minimize operative complications from an open
surgical approach. In addition, direct visualization of the procedure makes it safer than blind
pericardial punctures. Our team has utilized an immature porcine model implantation of cardiac
devices, and demonstrated the percutaneous approach was as safe and effective as an open
surgical technique.
The specific goal of this Phase II SBIR project is to demonstrate superior pericardial
access and epicardial pacing compared to a commercial trocar using a preclinical animal model
with infant growth rate, followed by first in human (FIH) clinical trials to accelerate regulatory
approval and commercialization of the PeriPath tool. In this work, we will complete the following
3 specific aims:
Aim 1: Demonstrate superior performance and usability to a commercial trocar as
measured by device performance and handling in tissue plates. We will conduct a pilot verification
build of the PeriPath device in compliance with FDA regulation. Devices will be subjected to
usability, verification, and validation testing and results compared to an EndoPath trocar using a
two-one-sided test. Success is defined as PeriPath achieving superior performance and
pericardial access compared to the commercially available trocar in all tests.
Aim 2: Demonstrate stable pacing parameters in a chronic pacing study. We will compare
the chronic pacing performance of leads implanted with the PeriPath tool to leads implanted with
the EndoPath trocar. The 12-week study will use a porcine animal model with a growth rate
equivalent to a newborn. We will measure pacing outcomes as well as device usability and tissue
healing. We will combine the results from Aim 1 to request an investigational device exemption
(IDE). Success is defined as superior usability, stable pacing parameters, and better tissue
healing scores for the PeriPath tool compared with EndoPath.
Aim 3: Perform a first in human feasibility clinical study using PeriPath to implant a
commercial pacemaker lead. Using the IDE obtained in Aim 2, we will request institutional review
board (IRB) approval at Children’s National (CN) to implant a commercially available pacing lead
in a five patient feasibility study. The study will demonstrate safety and efficacy of the PeriPath
device. Lead stability and pacing parameters will be monitored. Success is defined by completion
of the human feasibility study, and submission of a 510(k) application.
This research could have a transformative impact in changing current clinical practice by
converting an open surgical approach to a minimally invasive percutaneous procedure. While the
study design focuses on the unique needs of infants and children with congenital heart disease,
extrapolation of these findings may benefit thousands of adult patients who have indications for
cardiac resynchronization therapy but do not achieve successful implantation due to lack of
transvenous access or adequate coronary sinus venous tributaries to pace key locations in the
left ventricle, which could be resolved with our proposed tools and techniques.

Public health relevance
Project Narrative We are proposing novel tools and techniques to place pacemakers and cardiac defibrillators in infants and children with congenital heart disease, who cannot receive devices via transvenous route. This system allows for minimally-invasive port access with direct visualization of the heart for safer implantation and avoiding the need for open-chest surgery. We hope this provides an important solution for this unique group of pediatric patients who are currently precluded from receiving standard pacemaker and defibrillator therapies.